Transcription of Protein-coding Genes in Leishmania

Despite more than 20 years of molecular investigation. little is currently known about the essential process of the transcriptioo of protein-coding genes in Leishmania and other trypanosomatids, other than that it differs from that in other eukaryotes because mature mRNAs are generated by transspncing of large polycistronic primary transcripts. Moreover, there is no evidence fO( the transcriptional regulation of gene expression typically seen in other organisms. Previous worK from our laboratory has shown that transcription initiates at ooly a small number of sites between large (50-500 kb) divergent clusters of adjacent protein-coding genes on the same DNA strand and proceeds bi-directionally before temlination at the junction between convergent gene clusters. However, the 'promoter" elements involved in transcription inillation remain a mystery. In other eukaryotes, histone modification and chromatin re-modeling are important for activation of transcription, and recent experiments suggest that this may also be the case in trypanosomatids. This has ted us to hypothesize that the strand-switch regions between divergent PGCs recruit chromatin-remodenng complexes which modify histones and alter the local chromatin structure in these regions to allow access by the RNA polymerase II preinitiation complex, which then initiates transcription in both directions. In this proposal, we will test this hypothesis and build on our current work to further characterize the chromatin-modifying enzymes that are involved in transcription initiation.

Public health relevance
Project Narrative Human infections with the various species of Leishmania parasite cause substantial morbidity and mortality in tropical and sub-tropical countries world-wide. These organisms appear to differ from their animal hosts in the way that they transcribe the genetic information in DNA into messenger RNAs, which are used to make proteins. These studies are designed to identify parasite-specific differences in the transcription machinery, which we hope may be exploited for the development of novel anti- Leishmania drugs.